Drug Abuse and Related Health Disparities: An Intergenerational Longitudinal Study of Offspring of Delinquent Youth (Northwestern Offspring Project)

Every year in the United States, more than 900,000 juveniles are arrested and approximately 250,000 court
cases result in incarceration. Racial/ethnic minority youth and adults are disproportionately incarcerated,
especially for drug crimes. To address health inequities, we are currently conducting the Northwestern
Juvenile Project (NJP), a 16-year longitudinal study of health outcomes of youth after detention. Substance
use disorders (SUDs) were the most common psychiatric disorders at detention (affecting about one-half of
males and females), the most common comorbid disorder, and the most persistent disorder, affecting 1 in 5
participants in young adulthood. Many delinquent youth become parents when young; their offspring are at
great risk for SUDs and related problem behaviors. The proposed investigation, the Northwestern Offspring
Project, will be the first prospective study of intergenerational transmission of SUDs in the children of
delinquent youth. The Northwestern Offspring Project addresses the limitations of prior intergenerational
studies, many of which were conducted overseas and therefore unable to address health inequities in the
United States. We propose to study n=428 offspring (ages 12-15 years), their parents, n=428, and an
additional primary caregiver, estimated n=261. We chose ages 12-15 years because it is a critical developmental
period for substance abuse. Leveraging prospective data that have already been collected on parents (up to 14
interviews), the Specific Aims will investigate: (1) intergenerational transmission of substance use, SUDs, and
related problem behaviors in offspring; (2) mechanisms of intergenerational transmission, focusing on the
exposure of the child to the parents' substance abuse and to the collateral consequences of the parents'
incarcerations; and (3) resilience, examining the protective effect of a supportive and prosocial environment.
The proposed investigation is innovative by focusing on: (1) parents who have been in the correctional system;
(2) the consequences of incarceration; (3) African Americans and Hispanics, groups that are disproportionately
incarcerated and who face the most serious consequences of drug abuse; (4) use and disorder, examining 10
subcategories of substances: marijuana, cocaine, hallucinogen/PCP, opioid, amphetamine, inhalant, sedative,
unspecified drug, alcohol, and tobacco; (5) resilience to intergenerational transmission in an exceptionally
high-risk population; (6) patterns of homotypic and heterotypic continuity. The proposed study responds to
(1) the National Academy of Medicine's call for translational research to address the social determinants of
health disparities; (2) the NIMHD Strategic Plan, which requests studies to address disparities in the causal
factors of substance abuse; (3) the NIAAA Health Disparities Strategic Plan to build a knowledge base for
populations that have received less attention in studies of alcohol abuse; and (4) the NIDA 2016-2020 Strategic
Plan to identify environmental, behavioral, and social causes and consequences of addiction and determine
mechanisms that underlie individual risk and resilience for addiction.

Public health relevance
PROJECT NARRATIVE More than 900,000 juveniles, disproportionately African American and Hispanic, are arrested each year. Many become parents, and their children are at great risk for poor outcomes. The Northwestern Offspring Project will be the first study to examine the intergenerational transmission of substance use disorder and related problem behaviors in the offspring of delinquent youth.